Downshifting Sweet Preference and Added Sugar Intake During Snacking Among Young Children: A Randomized Controlled Trial

PROJECT SUMMARY AND ABSTRACT
The World Health Organization calls on all countries to reduce sugar intake among children because of the
solid evidence that limiting intake of free (added) sugars reduces the risks of obesity, tooth decay, and later
heart disease. In the United States, preschoolers are consuming, often in the context of snacking,
approximately 13 teaspoons of added sugars daily, more than double what the American Heart Association
recommends for children. Evidence-based strategies to effectively reduce added sugar intake and promote
the liking of beverages and foods containing less added sugar are a clear public health priority.
Our proposed randomized controlled trial builds upon our prior NIH-sponsored research that demonstrates
the plasticity of preferences during early life and the fundamental role that repeated exposure has on
shifting preferences. We have established that children have inborn, elevated preferences for sweet taste,
that sugary snacks are often offered for nonnutritive reasons by mothers, and that personal variation in the
reward sensitivity and appetitive tastes may make some children more susceptible to dietary excess of
sugars from snacks. This proposed research will be the first randomized controlled trial to determine
whether sweet preferences can be downshifted in preschoolers by a 4-month exposure to daily snacks
containing reduced levels of added sugars and sweetness (intervention group) compared to a similarly aged
control group whose daily snacks will be more than twofold higher in total sugar and fivefold higher in added
sugar (Specific Aim 1). We will also determine whether the impact of the intervention generalizes to other
foods as reflected by greater liking and intake of novel low-sugar snacks in the laboratory and by lower free-
living intake of added sugars, validated by biomarkers of cane and corn sugar, the two predominant added
sugars in the US food supply (Specific Aim 2). We will further examine whether inter-individual variation in
taste genotype, appetitive regulation traits, and reward sensitivity determines whether certain children are
less successful in shifting preference than others (Specific Aim 3). The Secondary Aim will explore the
trickle-down effects of the intervention on mothers by examining the extent to which their sweet preferences
are affected by feeding their children snacks with lower levels of sugar and sweetness.
To accomplish our goals, we have assembled a multi-institutional, interdisciplinary team of investigators,
each of whom brings unique and necessary expertise in human taste perception and genetics, child
appetite regulation, biomarkers, pediatric dentistry, and statistical methods. Findings will provide new insight
on family-based, personalized approaches for increasing young children’s liking of foods lower in added
sugar and sweetness. This research will serve the long-term goals of establishing evidenced-based
strategies to reduce children’s consumption of added sugar and promoting healthy snacking behaviors.

Public health relevance
RELEVANCE: PUBLIC HEALTH NARRATIVE STATEMENT What we eat during childhood helps program food preferences and later-life health outcomes, yet from two years of age a child is more likely to consume a manufactured sweet in the home and as a snack than a fruit on any given day. This proposed randomized controlled trial will examine the effectiveness of systematically reducing exposure to added sugars in increasing preferences for lower levels of sweetness in snacks among preschoolers, whose diet, like that of their mothers, is typically high in added sugar; we take a personalized approach by determining how variation in taste genotype, appetitive regulation, and rewarding properties of sweet taste, independent of body weight, impact the efficacy of the intervention. The knowledge gained will lead to targeted nutrition-related recommendations and policies for reducing added sugar intake in children, which will have widespread health implications for the prevention of obesity, dental caries, and cardiovascular disease in future generations.